Towards Multisystem-Brain Successful Aging in Schizophrenia Spectrum

Project Summary
Brain imaging research has revealed accelerated age-related white matter, neurochemical and perhaps
cortical changes in patients with schizophrenia spectrum disorders. However, imaging studies are typically
brain-focused without system-level investigations on the risk factors. Patients with schizophrenia spectrum
disorders also have a much shorter lifespan and high morbidity and mortality. However, medical comorbidity
studies typically do not include brain-based investigations. It remains unclear why schizophrenia spectrum
disorders have high age-related medical burden. Cumulative stress effects are predictive of successful aging in
healthy older adults. In patients with schizophrenia spectrum disorders, cumulative stress may disrupt brain
structure and function, and/or impaired brain structure and function may distort normal responses to stress
leading to increased cumulative stress effects. The proposal research will study cumulative stress and brain
imaging age-progression in an age span of 45 years, using a combined longitudinal and age-cohort cross-
sectional design. The study proposes to track the progression of stress-related risk factors in the periphery,
and the age-related changes in the brain, and to determine whether they will independently or interactively
contribute to age-related medical health and functional outcomes in patients with schizophrenia spectrum
disorders. These findings may guide the development of clinically actionable strategies to intercept abnormal
aging and promote successful aging in patients with this devastating illness.

Public health relevance
Project Narrative Schizophrenia spectrum disorders are associated with high morbidity and mortality rates from common medical conditions that normally increase with age in the general population. How a mental illness conceptualized primarily as brain disorder would have such negative multisystem medical consequence is not explained. This study attempts to identify what are the abnormal brain circuitry and brain-body interaction in the stress response system that may predict the exaggerated brain and body aging and the medical comorbidity in patients with schizophrenia spectrum disorders, so that we can develop better prevention and treatment to promote normal, successful aging.